The role of SUV39H1 in maintaining heterochromatin architecture and identity in Acute Myeloid Leukemia

PROJECT SUMMARY:
Acute myeloid leukemia (AML) is a malignant disorder of hematopoietic stem cells (HSPCs) where
normal 3D genome architectures are essential for proper lineage-specific functions. Repressive epigenetic
features, such as Histone 3 Lysine 9 trimethylation (H3K9me3), play vital roles in maintaining healthy HSPCs,
but we still understand very little about their roles in promoting AML. Marking constitutive heterochromatin,
H3K9me3 is deposited by methyltransferases and participates in heterochromatin condensation; however, its
significance in myeloid 3D genome architecture remains unclear. I identified SUV39H1, a key H3K9-specific
methyltransferase, as a major depositor in AML cells, essential for sustaining proliferation and myeloid
differentiation gene signatures. Moreover, in AML cells treated with DNA hypomethylating agents (HMAs),
alterations in H3K9me3 distribution are observed. This suggests a potential role of SUV39H1, the major
H3K9me3 depositor, in heterochromatin reorganization in the context of DNA hypomethylation. Together, I
hypothesize that SUV39H1-mediated H3K9me3 shapes AML-associated nuclear architecture, and that
the interplay between SUV39H1-driven H3K9me3 and DNA methylation status regulate heterochromatin
integrity. To test this, I will profile leukemic transcriptomic programming and assay the high-order genome
organization in SUV39H1-depleted AML cells to define the genomic mechanism in how SUV39H1 protect AML
cells from differentiation in Aim 1. I will determine if SUV39H1 is necessary for AML cells to survive DNA
hypomethylation by re-distributing H3K9me3 in Aim 2. This proposal seeks to investigate SUV39H1's role in
preserving 3D genome architecture in AML cells and identify it as a potential therapeutic target to augment
FDA-approved HMA therapy. If successful, this study will yield crucial insights into the determinants of 3D
chromatin organization in AML.
My ultimate career goal is to lead my own research team in genome and leukemia biology, driven by
my personal experience as a leukemia patient. The successful completion of my proposed work hinges on
mastering experimental methodologies and gaining in-depth knowledge in genomics and epigenetics. This
expertise will empower me to achieve my goals. Dr. Feng Yue’s laboratory, with its extensive expertise in both
leukemia biology and genome biology, is crucial for my training. By following the training plan outlined in this
proposal, I will receive comprehensive training in various techniques, acquire essential knowledge, benefit from
mentoring, and enhance my presentation skills. Conducting my research under the guidance and support of
Dr. Yue ensures that I am on the right path to achieve my goals.

Public health relevance
PROJECT NARRATIVE H3K9me3, a histone modification marking heterochromatin, is dysregulated in AML. This proposal seeks to investigate the role of SUV39H1, the major H3K9me3 depositor, in preserving 3D genome structure in AML cells and to explore its potential as a therapeutic target alongside FDA-approved HMA therapy. Successful completion of this study will yield crucial insights into 3D chromatin organization, offering innovative epigenetic approaches for treating myeloid malignancy.